Administrative Core COBRE Phase III Stem Cells and Aging

Administrative Core Project
Summary/Abstract
The Administrative Core is the foundation of the COBRE providing overall coordination for management of
the COBRE. The success of Phase 1 and Phase 2 of this COBRE has been dependent upon this Core which
will continue to lead this COBRE in Phase 3. The team consists of the founding director, Peter Quesenberry,
the Associate Director John Sedivy, five members of the External Advisory Committee (EAC), who bring
expertise in the relevant areas of research, the Internal Advisory Committee consisting of academic and
administrative leaders at our institutions and the Steering Committee containing key COBRE participants. In
addition, the leadership team has been enhanced by the addition of individuals specifically skilled in
development of clinical protocols, RNA studies and biostatistics.